Cancer Research Training & Education Coordination CRTEC

CANCER RESEARCH TRAINING & EDUCATION COORDINATION (CRTEC): ABSTRACT
The University of Kansas Cancer Center (KUCC) Cancer Research Training & Education Coordination
(CRTEC) component coordinates and provides essential cancer-focused education, training, and career
enhancement annually for >500 trainees and ~200 healthcare professionals. The CRTEC team and leadership
(Danny Welch, PhD and Lisa Harlan-Williams, PhD) works closely with Community Outreach and
Engagement (COE) and educators from four KUCC campuses to increase education and outreach to diverse
populations and cultivates an environment of lifelong learning throughout our catchment area. KUCC faculty
actively participate in training high school through post-graduate researchers in multiple biomedical and
healthcare fields by coordinating and integrating cancer education at all KUCC campuses. KUCC faculty have
developed new doctoral and certificate programs, provided research experiences (including for
underrepresented populations (URP) in the Kansas City metropolitan area); provided medical and nursing
continuing education curricula; developed specialized senior-to-junior mentoring and facilitated peer-to-peer
career development; assisted with grant preparation for faculty and trainees, and supported trainee travel.
CRTEC is leading institutional development of an integrated system for tracking and assessment of trainee
outcomes. KUCC trainees have made discoveries in basic, translational, clinical, and population science,
received numerous honors and awards, publications, and experienced >3-fold increase in extramural
fellowship funding since NCI designation. CRTEC is guided by three aims: 1) Continuously enhance an
infrastructure that facilitates center-wide training and educational programs that enrich collaborative and
interdisciplinary basic, clinical, translational, and population-based cancer research by engaging investigators
from multiple cancer-relevant research disciplines and backgrounds via a diverse collection of scientific and
educational initiatives; 2) Provide cancer research education and career enhancement opportunities across the
continuum of trainees and faculty, through stage-specific scientific and professional development activities that
promote and sustain a strong pipeline of diverse investigators and cancer care providers; and 3) Prepare
KUCC researchers to work with COE, community leaders and advocates, KUCC research programs and
shared resources to educate learners and teachers within KUCC and throughout the catchment area. These
aims will help fulfill the CRTEC vision – that learners receive high quality education, training, and mentoring so
that a well-trained, motivated, diverse, and equitable workforce of investigators and care providers can reduce
cancer burdens locally and beyond.